POST TRANSLATIONAL MOD ON RECOMB PECTIN DEGRADING ENZYMES &SUBSTRATE BINDING

We have continued to develop a WWW-based search engine for the CCRC-Net for a data set of 1H-NMR spectra of glucuronoxylomannans (GXMs) from Cryptococcus neoformans compiled by Drs. Cherniak and Morris. This search engine is capable of quantitatively analyzing GXM 1H-NMR spectra, giving an accurate estimate of the mixture ratio of the six possible GXM chemotypes in the sample. The importance of C. neoformans as an opportunistic pathogen in immuno-compromised patients has increased dramatically in recent years, particularly in patients with AIDS. Greater than 90% of the cell envelope of the yeast is carbohydrate; the major cell envelope component is the capsular carbohydrate GXM. GXMs serve as the basis for the current serotyping scheme for the yeast. The unique difficulty of this project was that all the spectra that were presented to the neural network during training were spectra of mixtures. The results demonstrate the ability of neural networks to analyze the components of a mixture spectrum without having seen pure spectra of its individual components during training. This recognition capability is particularly useful in the case of mixtures, as it is often difficult to separate their components by chemical methods. An article has been published describing this quantitative analytical technique. An R01 grant has been awarded by NIH to support this project.